Defining the mechanisms of nuclear pore complex assembly in fission yeast

Project Summary Unchanged from the parent document.

Public health relevance
Project Narrative Unchanged from the parent document.